Role of Environmental Weathering and Gastrointestinal Digestion on the Bioavailability and Toxicity of Microplastic and Cadmium Mixtures - A Platform for Undergraduate Interdisciplinary Training

Project Summary
Microplastics (MPs) represent an emerging human health hazard as either a direct environmental contaminant
or as a component of other mixed pollutants. Microplastics in the environment are exposed to ultraviolet
radiation (UV) that change their chemical, morphological composition, and reactivity. Microplastics frequently
interact with other heavy metals (e.g., cadmium (Cd)) in contaminated aquatic systems. Fish are continuously
exposed to UV-degraded MPs directly by accidental ingestion or indirectly by ingesting pray contaminated with
MPs. Humans are mainly exposed to MPs via ingestion of contaminated food and water. The fate of MPs
during digestion is largely unknown. The key barrier to advancing our understanding of the health risk of MPs
is a lack of information linking MPs’ environmental chemical transformations with bioaccumulation of MPs, and
specific health impacts. Our overall goal is to involve undergraduate researchers in an interdisciplinary
environmental engineering and toxicology project that targets key knowledge gaps of MP transformation,
reactivity, bioavailability, and toxicity to develop a strong set of skills in undergraduate students that
encourages to pursue a graduate degree and career in STEM. The overarching objective is to use quantifiable
approaches and innovative tools to better understand the role of environmental weathering and gastrointestinal
digestion on the bioavailability and toxicity of MPs and MPs and cadmium mixtures. We hypothesize that
ultraviolet weathering of MPs increases sorption of legacy pollutants (i.e., Cd) and gastrointestinal processes
affect their bioavailability and toxicity at the intestinal epithelium. Moreover, considering that MPs are taken up
via endocytosis we propose that MPs can interfere with endosome and lysosome function, specifically affecting
essential trace metal metabolism. To test this hypothesis, we propose the following interconnected aims:
Specific Aim 1: Evaluate the transformation and reactivity of ultraviolet-aged micro- and nanoplastics in
freshwater, commercial mineral water, and gastrointestinal (GI) fluids (i.e., during digestion); Specific Aim 2:
Evaluate the bioavailability and acute toxicity of MPs and MPs/Cd mixtures in intestinal cells form fish
RTgutGC cells, and human Caco-2 cells. The goal of aim 2 is to investigate the link between MPs type (size
and composition) and chemical modifications (aim 1) to bioavailability and acute toxicity of MPs alone or in
combination with Cd. Specific Aim 3: Evaluate the physiological impact of MPs on intestinal cells: using data
from aim 1 we will select MPs with higher reactivity and sorption capability and using data from aim 2 we will
select subtoxic but detectable doses of MPs and MPs/Cd mixtures and evaluate their impact on essential trace
metal homeostasis and metabolism. Our results will contribute to bridge the knowledge gap between chemical
transformations of MPs in the environment and implications on fish and human health. Our project will serve as
a platform for integrating undergraduate students into multidisciplinary research and will allow them to acquire
multiple skills spanning from environmental chemistry to cell biology and toxicology.

Public health relevance
Project Narrative The overall goal of our R15-AREA proposal is to involve undergraduate students in an interdisciplinary environmental engineering and toxicology project that investigates the impact of microplastics (MPs) on environmental and human health. We will train students to use quantifiable approaches and innovative tools to better understand (i) the chemical transformations of MPs in freshwater and gastrointestinal digestive fluids; (ii) the affinity of microplastics to the heavy metal cadmium (Cd); and (iii) the adverse effects of MPs and MP/Cd mixtures on intestinal cells. Our proposed study will elucidate the potential toxic effects of specific microplastic chemical transformations while developing a strong set of research skills in undergraduate students that encourages them to pursue a graduate degree or a career in STEM.